ALPHA INTERFERON AND ALL TRANS RETINOIC ACID FOR CERVICAL CARCINOMA

This protocol will determine the objective response rates, duration of response and survival in women with advanced, recurrent or inoperable carcinoma of the cervix to All-trans retinoic acid/alfa-interferon therapy and to evaluate the toxicities of this systematic therapy.